Regenerative potential of novel skeletal progenitors

Project Summary
Despite the enormous regenerative capacity of skeletal tissues, failed bone repair affects up to 10% of long-
bone fracture patients. Issues of skeletal healing also affect bones of the craniofacial region, where over 12
million people experience craniofacial skeletal injury in the United States annually. Options for prevention and
treatment of these healing issues are severely limited in clinical practice, and a comprehensive mechanism of
most regenerative processes remains poorly defined. The periosteum and bone marrow stroma are required for
efficient fracture healing as sources of osteochondral progenitor cells during new bone formation. We aim to
advance the understanding of bone-specific progenitor cell populations for applications in skeletal regeneration.
Leucine-rich repeat-containing G-protein coupled receptor 6 (Lgr6) is an adult stem/progenitor cell marker that
additionally functions as an auxiliary receptor in the Wnt/β-catenin pathway. While Lgr family members are often
expendable for normal function when stem cell populations are static, they can become important for cell
expansion and regeneration following injury. Our preliminary data suggest Lgr6 marks a population of
osteochondral-lineage cells, and Lgr6 is expressed in progenitors following skeletal injury; this indicates a subset
of adult stem cells associated with regenerative processes of the skeleton. However, a specific role for Lgr6 in
the context of fracture healing has not been explored, to our knowledge. In Aim 1, I will use a reporter mouse
model to trace the contribution of novel Lgr6+ adult osteoprogenitor cells to the fracture healing process. In Aim
2, I complement the analysis of progenitor fate in Aim 1 by investigating signaling pathways that may involve
Lgr6 expression in bone-specific progenitor cells. Overall, the proposed aims combined are designed to reveal
potential therapeutic targets to aid in skeletal regeneration. This will provide novel tools for fracture healing
studies. The conclusions from this project will have broad future applications, particularly in skeletal healing of
the craniofacial region.

Public health relevance
Project Narrative This project aims to identify and characterize novel regenerative adult stem/progenitor cells involved in fracture healing. Osteochondral progenitors in the periosteum and bone marrow are required for efficient skeletal repair. Compromised, non-healing fractures pose a significant public health problem; understanding the molecular drivers of progenitor-mediated skeletal regeneration will help to develop new therapies to reduce the incidence of delayed union and nonunion in fracture healing of both long bones and the craniofacial region.